The role of maladaptive VEGFR2 signaling in renal stroma for chronic kidney disease

PROJECT SUMMARY/ ABSTRACT
A dire consequence of acute kidney injury (AKI) is a dramatically increased risk to develop chronic kidney disease
(CKD). CKD accounts for 6.7% of Medicare expenses. Understanding the mechanisms by which AKI progresses
to CKD is essential for developing therapies, for which none currently exist. Renal microvasculature, including
pericytes and endothelial cells, are damaged in AKI, leading to recruitment of inflammatory cells which
contributes to progression to CKD. However, cellular, and molecular mechanisms that drive this process are
largely unknown. Pericytes are a heterogeneous mesenchymal population and have been identified as a major
source of myofibroblasts that drives CKD. Understanding the molecular mechanisms that mediates maladaptive
endothelial-pericyte crosstalk leading to exacerbated and prolonged inflammation could drive therapeutic
exploitation of this phenomenon. Previously, it has been shown that the systemic blockade of Vascular
endothelial growth factor receptor 2 (VEGF-R2) blocks CKD progression. My preliminary data, knocking out
VegfR2 in renal stromally derived cells (RSC) (termed VegfR2RSC-/-) that includes pericytes, confirms the
protective nature of this loss-of-function. I found that, in CKD models by renal ischemia/ reperfusion injury (IRI)
as well as by cisplatin, VegfR2RSC-/- mice have attenuated CKD progression, along with having mitigated
inflammation and preserved vascular function. My bulk RNA-sequencing analysis with isolated RSCs
demonstrates that inflammatory pathways are activated while short-chain fatty acid metabolism pathways are
suppressed during AKI-to-CKD transition. Mechanistically, VegfR2RSC-/- kidneys (1) have reduced expression of
a pro-inflammatory signaling axis of Thrombospondin-1 (TSP1)/ CD148, and (2) have increased expression of
fatty acid metabolism associated genes contributing to the enhanced protection. To home in on the timing of the
protection, I have generated a tamoxifen-inducible RSC-specific VegfR2 knockout (iVegfR2RSC-/-) mouse. I found
that, after pre-treatment of tamoxifen, iVegfR2RSC-/- mice are significantly protected against AKI. Together, these
data informed my overarching hypothesis that renal pericyte-specific VEGF-R2 signaling dysregulates pericyte-
endothelial crosstalk stimulating inflammation to exacerbate CKD. I propose the following aims to test this: Aim
1 will test the hypothesis that pericyte-specific VEGF-R2 signaling exacerbates AKI-to-CKD transition. Aim 2 will
test the hypothesis that pericyte VEGF-R2 signaling mediates maladaptive pericyte-endothelial crosstalk to
exacerbate inflammation, promoting AKI-to-CKD. Aim 3 will test the hypothesis that inhibiting VegfR2 signaling
in renal pericytes enhances vascular repair, mitigates inflammation, and blocks progression to CKD after AKI.
For the K01 Award, I enlisted innovative mentors. The University of Pittsburgh has an extraordinary number of
faculty with research programs focused on AKI, and on vascular medicine. Successful completion of these
studies will shed light on how renal pericyte specific VEGF-R2 signaling exacerbates CKD progression.

Public health relevance
PROJECT NARRATIVE Acute kidney injury is a common kidney disease, often found in critically ill patients, which is induced such as by sudden cardiac arrest or by side effects from a chemotherapeutic agent. A dire consequence of acute kidney injury is progression to chronic kidney disease, which accounts for approximately 6.7% of all Medicare expenditure. This study will combine the use of cultured kidney cells with genetically modified mouse models and pharmacological approaches to investigate whether a gene termed VEGF-R2 plays an important role in acute kidney injury to chronic kidney disease progression.